Integrative Structural Biology in DNA Replication and Damage Response

PROJECT SUMMARY
Faithful replication of DNA and response to encounters with aberrant DNA are essential to cell propagation
and survival. Our long-term goal is to understand the action of multi-protein DNA replication and damage
response machinery at eukaryotic replication forks. Our strategy is to elucidate the structural mechanisms
using an integrative structural biology approach, coupled to biochemical/biophysical characterization and
collaborations to define functional implications. This proposal focuses on critical unsolved questions about the
initiation of daughter strand synthesis in replication, and the stalling and remodeling of replication forks upon
encountering aberrant DNA. In DNA replication, the processive polymerases δ and ε require a short primer
strand on the template to function, which is generated by DNA polymerase α-primase (pol-prim). Although 3D
structures have been determined for all components of pol-prim and the intact heterotetramer, these have
provided only limited mechanistic insights because structures of full-length protein with relevant substrates
and essential co-factors are lacking. To address this critical gap in knowledge, we propose to determine the
relevant structures using Cryo-EM. We also propose to continue working on characterizing the structure,
biochemical properties and functional roles of 4Fe-4S clusters in pol-prim. We will test and refine our
hypotheses about the role of: (i) primase 4Fe-4S cluster redox in modulating DNA binding activity; (ii) the role
of the cluster in polα in driving the transition from RNA synthesis by primase to DNA synthesis by pol α.
Together, these studies will solve the fundamental questions about how pol-prim counts the length of the
primer at each step and how substrate hand-offs occur from primase to pol α and then from pol α to pols δ or
ε. Our second project addresses two critical gaps in knowledge about replication fork encounters with
aberrant DNA. RPA and Rad51 are two highly abundant ssDNA binding proteins that have critical roles in the
stalling, reversal and stabilization of stalled forks. RPA-coated ssDNA is the initiating signal for damage
response pathways and plays several additional roles, including recruiting and directing the fork reversal
activity of the ATP motor protein SMARCAL1. We propose to elucidate the mechanisms that drive this
important aspect of fork remodeling by determining the structure of the RPA and SMARCAL1 on a model fork
substrate complex using Cryo-EM. Rad51 plays an essential role in the stabilization of stalled replication
forks. Collaborative studies led to the discovery and characterization of RADX, a new DNA damage response
protein involved in regulating the activity of Rad51 at stalled forks. RADX also interacts physically with RPA,
suggesting there is a RPA-RADX-Rad51 network operating at stalled forks. We propose combined structural,
biophysical and functional analyses of RADX and its interactions with DNA, Rad51 and RPA to clarify the
roles of RADX at stalled replication forks. Together, our two projects will greatly enhance understanding of
how DNA is processed at eukaryotic replication forks and genomes are maintained and propagated.

Public health relevance
Narrative Faithful replication and maintenance of our genomes, which is vital to our survival, requires the action of complex multi-protein machinery that replicates our DNA and responds respond to aberrations in DNA that arise as a by-product of exposure to environmental toxins, sunlight, and even molecules produced naturally in cells. Defects in these protein machines lead to mutation and ultimately cancer and other diseases associated with genomic instabilities. Investigating the three-dimensional structure of the protein components of DNA replication and damage response machines and their interactions with each other and with the DNA will reveal intricate details of how replication and damage response occurs, what is defective in disease-associated mutant proteins, and open up new avenues for development of targeted therapies for patients suffering from maladies such as cancer that arise as a result of genomic instability.